ASSOCIATION OF NEUROPSYCHIATRIC DISEASE WITH AUTOANTIBODY PRODUCTION IN SYSTEMIC

The major goal of the current studies is to determine whether systemic lupus erythematosus (SLE) patients with elevated serum levels of anti-P antibodies, but no overt neuropsychiatric disease, demonstrate greater psychologic distress or cognitive impairment when compared to anti-P negative patients and other control groups.